A Human Factors Approach to Mitigating Speech Communication Interference in the Operating Room

Project Summary
Miscommunication in the Operating room (OR) is a leading cause of preventable error. Today’s OR is
a loud, complex sound environment, threatening unobstructed communication between team
members. Reducing hospital noise levels has been shown to have a direct impact on improving
patient safety, yet today’s OR contains multiple, competing sound sources: surgical machinery
coupled with intensified layers of simultaneous relevant and irrelevant conversations. These sources
cause a specific type of miscommunication: Speech Communication Interference (SCI), impeding the
team’s ability to communicate with each other, distracting from monitoring patient safety, and
interfering with maintaining a safe care environment. There is a critical need to examine the larger
context of the OR sound environment that leads to miscommunication. We propose groundbreaking
research in surgical error prevention by applying Human Factors principles to OR miscommunication,
including carefully selected evidence-based interventions from other industries. Our overall mission is
to use a Human Factors approach to study the impact of the sound environment on communication in
the OR and the execution of tasks necessary for monitoring patient safety. We will use the findings to
develop and evaluate interventions to enhance overall communication in the OR. Using video and
audio recordings, we will create detailed timelines surrounding Communication Interference events
and interview the participants in that failed communication. Applying Human Factors frameworks will
provide a rich understanding of the impact of overlapping conversations and environmental noises on
patient safety. We will guide a team of content experts, including surgeons, anesthetists, nursing
staff, and hospital leaders in the development and testing of interventions to improve OR
communication. Outcomes will be measured, both pre-intervention and post-intervention, at three
levels: the individual, process and system and will include important clinical outcomes such as
hemorrhage and desaturation. We will use acoustical methods to predict noise interference and
listener testing, for validation. Finally, we will test the interventions at a second hospital to ensure
generalizability. The study will occur at University Health Medical Center and Childrens Mercy
Hospital, providing care to underserved patients, many without commercial insurance. Our lab has
years of experience videorecording in the OR, creating timelines, and conducting interviews, finding
that they have an unparalleled ability to uncover near misses. This project will result in a set of
innovative interventions, grounded in a systems approach, to prevent, mitigate, and recover from
miscommunication, and will lead to a multi-center trial to test the effect of our OR communication
interventions on patient safety in diverse OR settings.

Public health relevance
Project Narrative The loud operating room (OR) environment is a distinct threat to unobstructed communication between OR team members that compromises patient safety. The current proposal will develop interventions surrounding overlapping conversations and environmental noise using a systems approach to prevent, mitigate, and recover from miscommunication. These interventions will provide an essential foundation for improving OR team communication and enhancing patient safety.